A Novel RAD51-BRCA2 Complex Stabilizing Drug: A Medical Countermeasure for Mitigating Accidental Radiation Exposure

Abstract
Ionizing radiation (IR) exposure from accidents or warfare can cause severe damage to radiosensitive tissues,
such as bone marrow, intestines, and blood vessels, leading to acute radiation syndrome (ARS) and delayed
effects of acute radiation exposure (DEARE) with high mortality and morbidity. These effects are mainly due to
DNA double-strand breaks (DSBs) induced by IR, which require efficient repair to maintain genomic integrity and
cell survival. We have developed small-molecule protein ligand interface stabilizers (SPLINTS), referred to as
MH analogs, that target the binding pocket of the BRCA2-RAD51 complex, a key component of homologous
recombination (HR), the most accurate and efficient pathway for DSB repair in S/G2 phases of the cell cycle.
Our preliminary results show that MH01, the most promising SPLINTS, can be administered hours after IR
exposure and mitigates cytotoxicity in a RAD51- and BRCA2-dependent manner, and enhances the repair
kinetics of radiation-induced DSBs in cell culture models. However, the precise mechanism by which MH01
stabilizes the BRCA2-RAD51 complex and enhances its functions during DSB repair and break-induced
replication is still elusive. Remarkably, we found that MH01 treatment 24 hours after lethal whole-body irradiation
(WBI) rescues 80% of mice from IR-induced death and reverses intestinal toxicity. However, the optimal dose,
pharmacokinetics, biodistribution, pharmacodynamics, and mechanism of action of MH01 are still unknown. We
hypothesize that MH01 is a potent and safe SPLINTS that mitigates tissue damage caused by IR exposure by
enhancing HR-mediated DSB repair in the S/G2 phases of the cell cycle through BRCA2-RAD51 complex
stabilization. Our specific aims are: 1. Optimize the MH01 regimen for mitigating radiation toxicity by integrating
pharmacokinetics, pharmacodynamics, and biophysical assays; 2. Elucidate the mechanism underlying MH01-
mediated enhancement of the BRCA2-RAD51 complex's functioning during DSB repair following IR; and 3.
Evaluate MH01 efficacy in mitigating radiation gastrointestinal tract and cardiac toxicities. Our approach on
strengthening the stability of the BRCA2-RAD51 complex using SPLINTS at the peak of BRCA2-RAD51 activity
during radiation-induced DSB repair, signifies a paradigm shift in the modulation of DNA DSB repair. This novel
strategy presents a therapeutic avenue for mitigating radiation injuries in normal tissues with cells capable of
undergoing division. Our overarching objective is to establish SPLINTS as a new and potentially significant
inclusion in the current array of medical countermeasures designed to address accidental radiation exposure.

Public health relevance
Project Narrative Accidental radiation exposure poses serious risks to human health, causing both immediate and long-term harm. This proposal investigates the effectiveness of our newly developed small molecule, designed to target proteins involved in radiation-induced DNA repair, in mitigating mortality and alleviating long-term toxicity in preclinical animal models exposed to lethal whole-body radiation. The potential impact of these findings goes beyond immediate mitigation, offering substantial contributions to the development of a potent and safe medical countermeasure agent for the effective mitigation of long-term health risks associated with accidental radiation exposure.